Virologic and immunologic impacts of active viral persistence in lung AMs of HIV-1-infected, cART-suppressed individuals

Project Summary / Abstract
Persistence of HIV-1 in tissue reservoirs of therapy-suppressed, aviremic individuals is a major challenge
to HIV-1 cure. The viral reservoir consists of myeloid and lymphoid cells that harbor the virus through long periods
of combination anti-retroviral therapy (cART). Until recently, it was thought that HIV-1 provirus remains in a
transcriptionally-silent, latent state in these reservoir cells and only resumes viral transcription and virion
production upon activation from endogenous or exogenous stimuli. However, it is now evident that in a subset
of reservoir cells, the virus remains transcriptionally-active even under cART and continues to generate some
levels of viral RNAs and/or proteins. Even in absence of complete viral replication, persistent viral RNA and
protein production in these “active” reservoirs pose significant adverse immunologic and virologic consequences.
They can contribute to the chronic immune activation as well as impact viral rebound upon treatment interruption.
Along with the transcriptionally-silent, latently-infected cells, elimination of these viral transcriptionally-active
reservoirs would be necessary to achieve a cure for HIV-1.
Most of our current knowledge of active HIV-1 reservoirs is limited to studies of CD4+ T-cells in the
peripheral blood. The nature of active reservoirs in myeloid cells within tissue compartments have remained
largely uncharacterized. In our preliminary studies, we have shown that alveolar macrophages (AMs), which are
the predominant HIV-1-infected cell-type in the lung, continue to transcribe viral RNAs under long-term cART.
We have also shown that, unlike CD4+ T-cells, the levels of viral RNA-positive AMs do not decrease even after
years-long therapy. In this study, we propose to comprehensively characterize these active AM reservoirs in
therapy-suppressed individuals by addressing three specific questions: (1) how the proviral landscapes and
profiles of viral RNA transcripts in AMs compare between cART-naïve and treated individuals, (2) how does the
ongoing viral transcription affect immunological functions and survival of the active macrophage reservoirs and
(3) do active reservoir macrophages impact viral rebound and replication in the neighboring reactivation-capable
AMs and CD4+ T-cells. We will utilize state-of-the-art molecular, cellular and immunological methods and a well-
characterized human subject cohort to examine the specific aims. The study will provide fundamental scientific
knowledge about a new layer of complexity in HIV-1 persistence and reveal the biological significance of active
AM reservoirs. Understanding the molecular mechanisms of continued viral transcription in active AMs and its
adverse cellular effects will help in devising tailored strategies for eliminating these myeloid reservoir cells.

Public health relevance
Project Narrative HIV-1-infected individuals who are under long-term anti-retroviral therapy, can effectively suppress plasma viremia, but remain predisposed to co-morbidities that are often attributed to hyperactivated and suboptimal immune functions. Recent indications that a sub-group of virus-infected cells called “active reservoirs” continue to generate viral RNAs and/or proteins during the treatment period could potentially contribute to the co- morbidities as well as relapse of viremia upon treatment interruption. We will extensively characterize the active viral persistence in lung alveolar macrophages to determine the roles of these reservoirs in viral rebound and immunological dysfunctions in therapy-suppressed individuals in order to identify molecular targets for their elimination.